Curation Core

Abstract - CURATION COMPONENT
The utility of the Gene Expression Database for Mouse Development (GXD) is proportional to its data content,
the quality of data annotations, and the level of data integration that we provide. To foster GXD’s mission to
facilitate insights into molecular mechanisms of development, differentiation and disease, the Curation
Component will continue and expand GXD’s curation of expression data and anatomical ontologies and ensure
high-quality data annotation and integration.
We will (1) continue the curation of classical types of expression data. We will collect and integrate
expression data from RNA in situ hybridization, in situ reporter knock-in, immunohistochemistry, RT-PCR,
Northern blot and Western blot experiments. Data will be acquired from the literature, via electronic data
submissions from laboratories, and by collaborations with projects that generate these data at a large scale.
We will continue to ensure high-quality data annotation and integration through our editorial processes and
quality controls. We will (2) continue and expand the curation of whole genome expression assays. Using
the detailed controlled vocabularies and ontologies employed in GXD/MGI, we will annotate GXD-relevant bulk
and single-cell RNA-seq and microarray expression data sets from GEO and ArrayExpress by attributes of the
samples used, thus maintaining and expanding GXD’s up-to-date, searchable index to allow researchers to
effectively find data sets of interest. We will continue to select consistently-processed, high-quality RNA-seq
expression data sets from EBI’s Expression Atlas for inclusion in GXD. We will (3) continue the curation of
anatomical ontologies and incorporate new anatomical concepts and relationships. We will enhance
and refine the Mouse Developmental Anatomy Ontology and add “develops-from” relationships between
anatomical structures of successive developmental stages to enable the analysis of differentiation pathways.
We will maintain and refine the integration of expression and phenotypic data by referencing common
anatomical objects, thus enhancing our tools for the direct anatomy-based comparison of expression,
phenotype, and disease data. We will begin to annotate expression data at the cell type level by combining
anatomy and cell ontology terms. We will extend the cell type (CL) ontology as needed by our annotation of
expression data, in collaboration with the CL developers.